Cell-specific role of NF-KB in necrotizing enterocolitis

DESCRIPTION (provided by applicant): Necrotizing enterocolitis (NEC) remains one of the most devastating diseases affecting premature babies and is the leading cause of intestinal failure in infancy, with currently no specific treatment available. Elucidating the mechanisms leading to NEC is essential so strategies that will improve the disease outcome can be designed in the future. We have evidence suggesting that nuclear factor-κB (NF-κB) and IKKβ (the inhibitor of NF-κB (IκB) kinase), the critical upstream kinase activating NF-κB, mediate the bowel injury in a neonatal rat model of NEC. However, the specific requirement of NF-κB activation in individual cell types for bowel injury to occur is unknown. Our laboratory has recently developed and characterized a mouse model of NEC that will allow us to utilize transgenic mice to dissect the mechanism of NF-κB-dependent bowel injury in NEC in vivo. Using mice with deletion of IKKβ in intestinal epithelial cells (IEC) or myeloid cells (MC), we have preliminary evidence that NF-κB in MC mediates the intestinal damage in a model of acute bowel injury. Furthermore, we also found that NF-κB in MC mediates the bowel injury in our neonatal mouse model of NEC. We believe that, in premature infants, perinatal stress and bacterial colonization initiate an increase in intestinal mucosal permeability at least in part through activation of NF-κB and production of downstream cytokines in IEC. However, the initial epithelial NF-κB activation alone does not lead to intestinal injury. We hypothesize that translocation of bacterial products to the lamina propria (LP) causes sustained activation of IKKβ (inhibitor of NF-κB kinase) and NF-κB in the LP MC and subsequent production of large amounts of pro- inflammatory cytokines and chemokines (e.g., CXCL2). This in turn leads to the recruitment of neutrophils and production of reactive oxygen species. As a result, there is further intestinal epithelial damage, including apoptosis and mucosal necrosis, and NEC. Thus, NF-κB activation in intestinal MC is pivotal for the development of NEC. Therefore, to test this hypothesis using the neonatal mouse model of NEC that we have developed in our laboratory, we propose to: 1) Test the hypothesis that IKKβ and NF-κB activation is required for NEC to develop; 2) determine the requirement for MC IKKβ activation in causing intestinal inflammation and injury; 3) determine the role for IEC IKKβ activation in the increase in intestinal permeability and in secondary mucosal cytokine and chemokine expression. By understanding the specific role of NF-κB in individual cell types such as IEC and MC in causing bowel injury in vivo, we will advance our knowledge of NEC, which will potentially lead to new therapeutic strategies. PUBLIC HEALTH RELEVANCE: This proposal aims at dissecting the mechanisms leading to necrotizing enterocolitis, a disease affecting premature babies with great morbidity and mortality. It uses genetically manipulated mice to study the role of a factor that regulates the gene transcription of inflammatory substances and contributes to intestinal injury.

Public health relevance
PROJECT NARRATIVE: This proposal aims at dissecting the mechanisms leading to necrotizing enterocolitis, a disease affecting premature babies with great morbidity and mortality. It uses genetically manipulated mice to study the role of a factor that regulates the gene transcription of inflammatory substances and contributes to intestinal injury.